Arrestin domain-containing protein 4 as a novel regulator of glucose metabolism in the ischemic heart

ABSTRACT
The complexity of cardiomyocyte signaling requires scaffolding proteins to coordinate the cellular processes
driven by receptors and transporters. β-Arrestins are prototypical intracellular scaffold proteins that negatively
regulate cardiac β-adrenergic receptor function via desensitization. Recently, a larger and more ancient family
of structurally related arrestins, termed α-arrestins, has been identified, which shares functions in regulating
transporter trafficking. Txnip, the best-studied member of α-arrestins, serves as an adaptor protein to facilitate
endocytosis of glucose transporters (GLUTs) and suppresses glucose influx through its arrestin domains. We
previously found that targeted deletion of Txnip leads to a substantial metabolic switch, directing
cardiomyocytes toward enhanced glycolytic metabolism under severe ischemia. Despite the potential to
identify new molecular mechanisms, the functions of other α-arrestins, Arrestin domain-containing protein
(Arrdc) 1-5, remain largely undefined in the heart. Here we present preliminary data demonstrating that two α-
arrestins Arrdc4 and Txnip are related to their conserved arrestin domains and share the function to inhibit
GLUT1. Interestingly, this metabolic inhibition was more potent in Arrdc4 than in Txnip. Using our recently-
generated Arrdc4 knockout mouse model, the data reveal exciting findings that inhibition of Arrdc4 enhances
myocardial glucose uptake during hypoxia and improves outcomes after myocardial infarction. These results
define the outlines of an Arrdc4-GLUT1 pathway that may provide a link between cardiac glucose metabolism
and cardiomyocyte survival. This project aims to delineate the molecular nature of this pathway and tests its
role in the pathogenesis of ischemic heart disease. Aim 1 tests three non-exclusive hypotheses by which
Arrdc4 regulates GLUT1 function in cardiomyocytes: (a) specific arrestin domains of Arrdc4 mediate clathrin-
dependent endocytosis of GLUT1; (b) Arrdc4 promotes GLUT1 ubiquitination through an E3 ligase-mediated
pathway; (c) Arrdc4 and Txnip are complementary in the regulation of cardiomyocyte glucose metabolism. Aim
2 employs the Arrdc4 knockout mouse model to test the overall significance of cardioprotection against
myocardial ischemia through a GLUT1-mediated mechanism in vivo. By genetically “reconstituting” the hearts
of Arrdc4 knockout mice with the informative Arrdc4 mutant, this aim also tests the roles of the specific
molecular mechanisms linking Arrdc4 and GLUT1 in ischemic heart disease. Furthermore, using a combination
of virtual screening and cell-based assays, Aim 3 will search for the possible Arrdc4-GLUT1 interaction
inhibitors that may improve energy homeostasis and enhance cardiomyocyte survival under hypoxia. These
studies are highly innovative as we propose a pathway that has never been entertained as a cardiac metabolic
regulator. The resulting knowledge will provide a novel mechanistic basis for understanding the defense
mechanism to protect cardiomyocytes against metabolically-challenging environments under ischemia. Thus,
we believe that the mechanism of action of Arrdc4 will give new and relevant insights into therapeutic strategy.

Public health relevance
PROJECT NARRATIVE Impaired energy homeostasis contributes to cardiomyocyte damage and adverse cardiovascular outcomes after myocardial infarction or circulatory arrest. We have discovered a new mechanistic pathway that controls cardiac glucose metabolism under ischemic stress. This project will delineate critical molecular aspects of the pathway and its role in the pathogenesis of ischemic heart disease.